Mechanisms of Post-transcriptional Gene Regulation by RNA Binding Proteins

PROJECT SUMMARY/ABSTRACT
This MIRA award supports our studies of how RNA binding proteins regulate alternative splicing and other
posttranscriptional steps in mammalian gene expression. The previous funding period was very productive with
multiple publications. We developed new methods and we discovered new interactions and new functions for
several proteins and RNAs. We propose to continue these studies applying our strategy for isolating splicing
regulatory complexes and snRNPs from the chromatin compartment of cells, characterizing their components,
determining their structures, and testing their impact on splicing regulation or other processes. We will complete
our structure by cryo-electron microscopy of chromatin-isolated U2 snRNP’s associated with the epitope-tagged
RBM5 regulator and bound to intron branchpoints. We will go on to determine the structures of U2 particles
associated with tagged SF3A2 and other factors. These structures will provide new insight into how regulators
like RBM5/10 and the RNA Helicase DHX15 alter splicing at a late stage of spliceosome assembly. We will apply
our method of chromatin extraction to new molecules including the U1 snRNP and polypyrimidine tract binding
protein 1. We expect to identify new interactions of these molecules by isolating them bound to their nascent
RNA substrate. These particles also will be examined by EM to assess their suitability for structure determination.
We will continue our studies of the Rbfox family of splicing regulators. Earlier studies of chromatin associated
Rbfox1 demonstrated its association with a complex of other RNA binding proteins (LASR) and its higher order
assembly through homomeric interactions of its disordered C-terminal domain. We will continue our analysis of
the residues that mediate this homomeric interaction and define a minimal segment conferring self-assembly.
Results from this analysis will enable manipulations of Rbfox/LASR assembly in vivo and studies of the role of
these complexes in splicing. These studies will also illuminate similar self-assembly reactions of disordered
domains implicated in the pathology of ALS. Finally, we discovered that MALAT1, a nuclear long noncoding
RNA, functions as an mRNA in neurons encoding a micropeptide that modulates expression of synaptic proteins.
We will futher explore this new function of MALAT1, examining how its translation and localization are controlled,
and whether it might encode additional peptides. Altogether our studies will illuminate diverse roles for RNAs
and RNA binding proteins in the expression of mammalian genes.

Public health relevance
PROJECT NARRATIVE Many forms of human disease, ranging from neurodegeneration to cancer, result from aberrant function of RNA binding proteins leading to mis-regulation of the pre-mRNA splicing reaction and other errors of cellular RNA metabolism. Despite their broad involvement in disease, how these proteins control splicing is not well understood, and this understanding will be essential to the development of splicing targeted therapies. In this project, we will study the mechanisms by which RNA binding proteins control splicing and other aspects of gene regulation.